Advancing & Improving Measurement and Value in Primary Care (The AIM-PC Starfield Summit)

Project Abstract: Our current health care system is overpriced and underperforming in part due to failure to nurture high- performing primary care. Related to this, the US lacks consensus on a parsimonious set of measures capable of focusing primary care on its high-value functions. To address these challenges and AHRQ’s priorities of improving health care affordability, efficiency and cost transparency, the Virginia Center for Health Innovation, in partnership with the Center for Professionalism and Value in Health Care and the University of Michigan VBID Center, is requesting a one-year AHRQ Conference Grant to support the convening, development of work products, and dissemination and implementation of results for the AIM-PC Starfield Summit, entitled “Advancing & Improving Measurement and Value in Primary Care.” Initiated in 2016, the Starfield Summits are “envisioned as an ongoing series of meetings” among a diverse group of leaders in primary care research and policy, intended to galvanize its participants, generate important discussion for public consumption, and enable research and policy agenda-setting in support of primary care function.? AHRQ was a supporter of the 3rd Starfield Summit that helped produce the Patient Centered Primary Care Measure which is now endorsed by CMS as a QCDR MIPS measure and which is going through NQF endorsement. We propose a 5th Starfield Summit to address the challenge of measurement in primary care. Nested within the broader conversation about “Measures that Matter for Primary Care”1-3 will be a focused conversation on how to specifically increase its value through measurement and reduction of low value care (LVC) by primary care providers. There are now hundreds of tests and procedures considered unnecessary, identified by the Choosing Wisely campaign, the US Preventive Services Task Force, international entities, and even commercial software. Desperately needed is consensus on which LVC measures matter most ? to payors, academics, clinicians, policymakers, and patients, especially those in priority populations. Our Summit and its summary writings will frame primary care LVC in the context of overall payment reform, review and identify the range of LVC recommendations, develop criteria for evaluating LVC measures, establish feasibility for LVC measure implementation, achieve consensus on a concise set of LVC indicators specific to primary care; and disseminate the selected measure set for widescale implementation. We will achieve this aim through the virtual assembly of leading LVC and primary care measures advisors and executing two rating and ranking surveys to yield desired deliverables.

Public health relevance
Project Narrative: Despite considerable effort to advance quality improvement, performance measurement, and a recent pivot toward paying for value intended to benefit the public, US healthcare continues to underachieve -- paying more for less value than its peers while putting patients at risk of physical, emotional and financial harm. Widespread dissatisfaction with care measurement is only amplified in primary care, where better alignment is needed so that assessment and payment policies reinforce what patients and clinicians know to be valuable: continuity, comprehensiveness, and the avoidance of low value services. Starting with a focus on low value care, we will convene a nationally-representative group of primary care and LVC measurement experts to establish criteria for evaluating candidate indicators and measures, and select a defined set for dissemination and implementation by payers.